Engineered gamma delta T cells for systemic correction of dystrophic epidermolysis bullosa

ABSTRACT
Recessive dystrophic epidermolysis bullosa (RDEB) is a severe autosomal recessive disease caused by
collagen type VIIa (COL7A1) gene mutations. RDEB is characterized by absent/defective COL7A1 (C7) protein
deposition causing severe blistering, mucosal tissue damage, and aggressive squamous cell carcinoma.
Palliative care is non-curative and cellular therapy options include autologous or allogeneic local and/or
systemic infusion of keratinocytes, fibroblasts, mesenchymal stromal cells (MSC), or hematopoietic
stem/progenitor cells (HSPC). None of these currently employed treatment options resolve the full pathological
spectrum of RDEB. Active wound areas persist, and mucosal disease remains highly refractory to intervention
contributing to significant morbidity. Keratinocytes and fibroblasts, the primary C7 producing cells, show limited
migration and persistence following localized injection. MSC and HSPC have broad circulatory potential,
however, they produce comparatively low levels of C7 and residence in the skin or mucosa is not well
established. Thus, it is essential to develop more efficacious cellular therapies capable of accessing skin and
mucocutaneous tissues. γδ T cells are abundant within skin and mucosa, and due to their MHC-unrestricted
nature are compatible with allogeneic transfer, however they do not naturally produce C7. Our approach will
employ a highly efficient and clinical stage non-viral transposon platform to engineer γδ T cells to produce high
levels of endogenous C7. We hypothesize that the tissue migratory properties of γδ T cells—particularly to the
skin and mucosa—as well as their demonstrated allo-compatibility, make them uniquely suited for therapeutic
delivery of C7 protein. In Aim 1 we will define a genome engineering strategy to confer high C7 expression in
human γδ T cells, and test critical safety parameters and commercial feasibility. In Aim 2, we will evaluate the
ability of engineered allogeneic γδ T cells to home to skin and mucosa, deposit C7, and ameliorate pathology
in an immunodeficient mouse model of RDEB, amenable for testing of these engineered human cells. Further,
we will test the effect of zoledronate induced in vivo expansion of the engineered Vγ9Vδ2 T cell subset on
therapeutic efficacy. Our approach is a highly novel and innovative allogeneic strategy designed to address key
limitations of current cellular therapies for RDEB. The application of engineered γδ T cells represents an
attractive protein delivery strategy with high translational potential for RDEB, other inherited mucocutaneous
disorders, and a multitude of diverse disorders treated by cell/stem cell transplant.

Public health relevance
PUBLIC HEALTH RELEVANCE Inefficient delivery of type 7 collagen (C7) to skin and mucosa limits treatment of recessive dystrophic epidermolysis bullosa (RDEB). Recent advances in non-viral genetic engineering have made it possible to engineer cells to express high levels of endogenous COL7A1, despite the large size of the COL7A1 cDNA. We will leverage this clinical stage technology to engineer a unique population of skin and mucosa resident immune cells to produce and deliver therapeutic C7 to target tissues, thus outlining a highly translational approach that is transferable to other disorders, and will lead to new discoveries to improve human health.